Husbandry Core

Bibliography
1. Zhang X KS, Ng J, Oldt R, Mankowski J, Adams RJ, Smith DG. Genetic Characterization of a Captive
Colony of Pigtailed Macaques (Macaca nemestrina). Lab Anim Sci 2017: 56(4):390-395. PubMed
PMID: 28724488
2. Capitanio JP, Abel K, Mendoza SP, Blozis SA, McChesney MB, Cole SW, Mason WA. Personality
and serotonin transporter genotype interact with social context to affect immunity and viral set-point in
simian immunodeficiency virus disease. Brain Behav Immun. 2008; 22(5):676-89. PubMed PMID:
17719201 Volume 4 The Department of Embryology. Cambridge University Press, 2004.